Characterizing Alzheimer's Risk in Retired Night Shift Workers: Cognitive Function, Brain Volume, and Brain Bioenergetics

PROJECT SUMMARY/ABSTRACT
Night shift work is common in the current 24-hour global society and is increasingly recognized as a risk factor
for Alzheimer’s Disease (AD) and related dementias (ADRD). However, we know very little about the
persistence, recovery from, or pathways through which shift work contributes to AD/ADRD. Neuronal
metabolic decline (i.e., disrupted brain bioenergetics) contributes to AD/ADRD development and progression,
and the repeated sleep and circadian disruptions in shift work compromise peripheral energy metabolism. This
K01 proposal will advance these findings by comparing indices of Alzheimer’s disease risk and brain
bioenergetics between retired night shift workers and retired day workers. N = 40 participants (n = 20 retired
night shift workers, n = 20 retired day workers) ages 65-80 from an established cohort will perform
neurocognitive assessments (e.g., episodic memory, executive function) and 7 Tesla neuroimaging. Structural
magnetic resonance imaging will assess hippocampal, posterior cingulate cortex, and retrosplenial cortex
volume and phosphorous magnetic spectroscopy will assess brain bioenergetics, including adenosine
triphosphate, phosphocreatine, and inorganic phosphate. This study will compare retired night shift workers
and retired day workers on cognitive function, brain volume, and brain bioenergetics, and will examine the
association of brain bioenergetics with brain volume among retired night shift workers. To conduct this
research, Dr. Lehrer will pursue a program of training that will advance his knowledge and skills in the
assessment of Alzheimer’s disease-related cognitive function, brain structure, and neurobiology (i.e.,
bioenergetics and AD-specific proteinopathy). He will also learn how to integrate these methods into his
emerging program of sleep and circadian rhythm and AD/ADRD research. This training, along with findings
from the proposed study, will allow Dr. Lehrer to launch his career as an independent investigator studying the
role that long-term sleep and circadian disruption plays in Alzheimer’s disease to inform impactful prevention
efforts for retired night shift workers. Study findings could influence our approach to AD/ADRD risk among
current and former shift workers, leading to early identification of at-risk individuals at the conclusion of, or
even during a career in shift work. Results will inform future studies using experimental approaches to test
causal relationships, inform development and dissemination of interventions, and elucidate precision medicine
approaches to prevent and attenuate the clinical course of AD/ADRD. Such interventions may include
potentially modifiable behavioral (e.g., sleep and circadian rhythm enhancement) and pharmacological (e.g.,
bioenergetics-boosting compounds) therapies for AD/ADRD intervention and/or prevention. The proposed
study will generate public health-relevant data that will help to reduce AD/ADRD risk and inform behavioral
and bioenergetics-focused therapies to prevent and mitigate the clinical course of Alzheimer’s disease and
related dementias among a large portion of current and former U.S. workers.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) and related dementias (ADRD) are the leading U.S. health concern of the 21st century, and night shift work is an increasingly recognized risk factor for AD/ADRD. The proposed study is the first in a broader program of research that will characterize AD/ADRD-related cognitive function, brain structure, and brain bioenergetics in retired night shift workers compared to retired day workers, generating evidence on the potential “scarring” of shift work exposure on Alzheimer’s disease risk. Findings will inform future experimental approaches to identify behavioral and pharmacological interventions to prevent and attenuate the clinical course of AD/ADRD in a large portion of U.S workers.